BCI-DEF: Brain Computer Interfaces and Disability: Developing an Inclusive Ethical Framework

Project Summary/Abstract
The objective of “Brain Computer Interfaces and Disability: Developing an Inclusive Ethical Framework (BCI-
DEF)” is to use structured vignettes, video-supported interviews, and a deliberative democracy approach to
assess and analyze diverse, critical stakeholder perspectives about the benefits, risks, and ethical challenges
of Brain Computer Interface (BCI) technology. BCIs measure and interpret brain signals and interface with a
device to allow users to perform a task, such as communication or movement. BCIs hold great promise,
especially for end users with disability due to neurologic deficits in communication or motor function, but this
potential may be limited by unaddressed ethical challenges. Issues of concern include stigma, autonomy,
privacy, safety, impacts to personhood, responsibility and justice. Through the innovative approach in this
project, we will focus on input from a primary group of potential end users (patients with neurologic disability
and their family/caregivers) and clinicians who care for patients with acute neurologic injury to obtain critical
and heretofore absent information about important focus areas related to ethics of BCI. The inclusion of
additional key stakeholders including BCI engineers and research teams will further inform the deliberative
democracy approach. Issues we will further investigate through this project include weighing the potential
benefits and risks of BCI; evaluating ethical challenges surrounding BCI and disability including those around
autonomy, stigma, and justice; impact of BCI on perceptions of disability and clinical decision making in acute
brain injury; and defining critical information needed by end users, families, and clinicians to make future
informed decisions about BCI use. This work is critical to ensure seamless, equitable, and ethical adaptation of
innovative and cutting edge BCI technologies being developed through BRAIN Initiative projects.

Public health relevance
Project Narrative Brain Computer Interfaces (BCIs) are innovative and cutting-edge technologies that measure and interpret brain signals to interface with a device that allows users to perform a task, and while BCIs hold great promise in their transformative potential for patients with neurologic disability, there are critical unaddressed ethical challenges that have the potential to limit their adaptation. This project will use innovative approaches including structured vignettes, video-supported interviews, and deliberative democracy to qualitatively evaluate end user perspectives about the benefits, risks, and ethical challenges of BCIs. Our transdisciplinary research team and the diverse input from patients with neurologic disability and their family/caregivers, clinicians who care for patients with acute neurologic injury, and BCI researchers and engineers will inform future decisions and policies about ethical and equitable adaptation of BRAIN-funded BCI technology.